The Role of Treg and Tpex Interactions in Tumor-Draining Lymph Node Immunosuppression and Immunotherapy Response

PROJECT ABSTRACT
Cytotoxic CD8 T cells are a necessary component of the anti-cancer immune response. When CD8 T cells
encounter chronic antigen stimulation, they become dysfunctional and can no longer effectively exude their
cytotoxic function1-3. Our lab and others have identified a CD8 stem-like progenitor, called Tpex, that retains its
ability to kill cancer cells4. It was found that upon immune checkpoint blockade (ICB) therapy, these Tpex cells
differentiate, egress from the tumor-draining lymph node (tdLN), and migrate into the tumor microenvironment
to kill the tumor via cell-mediated cytotoxicity4. When the tumor-draining lymph node has been metastasized
(metLN), this Tpex response is abrogated, and there is not a productive anti-tumor response with ICB4. Our lab
found that in the metLN, Tpex were present but were preferentially surrounded by suppressive Tregs and
DCs4. Additionally, Tregs are known to play an immunosuppression role in the TME and have a negative
impact on the effectiveness of many current immunotherapies5-8. How Tregs are affecting the environment in
the metLN and how Treg immunosuppression impacts other immune cell types, including Tpex, is not yet
known. This proposal will test the hypothesis that LN metastasis amplifies Treg function both directly and
indirectly to create an immunosuppressive niche in the metLN, limiting the function of Tpex cells and impairing
a proper CD8 T cell response to ICB. Aim 1 of this proposal will identify the mechanism by which Tregs are
creating an immunosuppressive environment in the tumor-draining lymph node. Aim 2 will define how Tregs
are impacting the Tpex functionality. Aim 3 will determine how the Treg-Tpex cell axis affects ICB response
and efficacy in the tdLN. This research approach will use a variety of methods, including an ex vivo organoid
model, high-dimensional flow cytometry, multiplexed ion beam imaging (MIBI), single-cell RNA sequencing,
and in vitro co-culture assays. These proposed studies will be among the first to study immune cell
interactions and Tpex cells using patient-derived lymph node organoids. These results could elucidate
novel mechanisms of immunosuppression in the tdLN and indicate how those mechanisms impact current
cancer immunotherapy. This would result in an improved understanding of Treg and Tpex function in the tdLN
and how ICB impacts them in the tdLN. The use of human-derived organoids as the primary model allows this
research to be greatly translationally relevant and inform our understanding of cancer immunotherapy
response, specifically in patients. Furthermore, this work will better inform novel immunotherapy approaches
for the treatment of patients with metastatic cancer, especially in the fields of biologics and adoptive T cells,
where preventing CD8 T cell exhaustion is a major goal. This research project and fellowship training will
be conducted at a top-funded research institution, the University of California, San Francisco (UCSF),
in the laboratory of Dr. Matthew Spitzer. Dr. Spitzer is an investigator with expertise in systems immunology,
cancer immunology, and CD8 T cell biology as well as spatial and single-cell sequencing methods. This mentor
and institution will provide a high-quality training environment with ample resources for the completion of this
research and development of professional skills required for a career in academic research.

Public health relevance
PROJECT NARRATIVE CD8+ T cell responses are necessary for anti-cancer immunity, and there is a reservoir of stem-like CD8+ precursors that exist in the tumor-draining lymph node that are critical for response to immune checkpoint blockade immunotherapy. When the lymph node is metastasized, Tpex proliferation and function is impaired, and the Tpex are found in close proximity to Tregs. How Tregs create an immunosuppression environment in the lymph node that restricts Tpex function in the tumor-draining lymph node is not well understood, and therefore this proposal will address that knowledge gap with the goal of improving immunotherapy strategies for cancer patients with metastatic disease.